Developing an Innovative Genomic Data Science Curriculum: Interdisciplinary Modules for Undergraduate Education

NOFO: RFA-HG-23-002
Title: Developing an Innovative Genomic Data Science Curriculum: Interdisciplinary Modules for
Undergraduate Education
Project Abstract
Computational Genomic Data Science (CGDS) combines aspects of genetics, statistics, and
informatics and is becoming increasingly important in biological research. However, CGDS
instruction is rarely integrated into life science curricula at the undergraduate level and is
essentially non-existent at the community college level, predominantly due to lack of faculty
training. An additional barrier at the community college level is lack of access to data sets
suitable for CGDS curriculum development. Leveraging cloud computing resources, like those in
available through the Genomic Data Science Community Network (GDSCN) and the All of Us
Research Workbench, we propose an interdisciplinary study integrating CGDS and social
determinants of health that would provide a sustainable educational pathway to a mentored
student research project for community college students. We propose a two-course sequence of
community college biology courses with embedded CGDS curricula that prepares students for
CDGS research or future CGDS studies. Contextualizing the curriculum to genetic studies of
social determinants of health adds a real-life context to the work while giving students the
opportunity to contribute to broader scientific knowledge. Using a peer-led team learning model
supports engagement, retention and success for both students and peer leaders, while
providing CDGS leadership experience for peer leaders. The program supports research and
innovation by: 1) engaging community college students in innovative CDGS research curricular
undergraduate research experiences using AnViL with the opportunity to earn CGDS
microcredentials , 2) cultivating interdisciplinary mentored student research projects among
community college and four-year college that can serve as a bridge to bachelor’s degree
research, and 3) increasing the participation in CGDS research by students underrepresented in
STEM, resulting in participants being co-authors on publications and presenters at scientific
conferences.

Public health relevance
NOFO: RFA-HG-23-002 Title: Developing an Innovative Genomic Data Science Curriculum: Interdisciplinary Modules for Undergraduate Education Project Narrative This project will increase participation in genomic data science research by community college Black and Latino/a/x students, who are historically underrepresented in this field. The hallmark of this project is that students will be able to contribute to the field of health disparities while learning highly marketable skills in genomic data science, including R coding and cloud computing, while building their knowledge in genomics. Ultimately, this project gives students a real-life, multidisciplinary lens through which to find their fit in contributing to better health outcomes for the communities in which they live and work.